Mechanisms Regulating B2AR Sorting to Signaling Microdomains

PROJECT SUMMARY
The beta 2 adrenergic receptor (B2AR) is a G Protein Coupled Receptor (GPCR) that plays a significant role in
catecholamine signaling in the heart, especially during periods of heart failure. B2AR signaling in heart failure is
incompletely understood, with contradictory data indicating both cardioprotective and deleterious impacts. It has
become clear in recent years that changes in B2AR localization within the cell are major regulators of signaling
and contribute to variation in response to differential stimulation at the same receptor. Once activated, B2AR
can signal via the cognate G protein Gs at the cell surface and in intracellular endosomal compartments. The
endosomal signaling promotes transcription of particular genes, most of which are not stimulated by B2AR
activation at the plasma membrane. Gs activation by B2AR at endosomes is tightly controlled by posttranslational
modifications of the B2AR C-terminal tail. Phosphorylation of serines 345 and 346 (SS345/6) on the receptor tail
by protein kinase A (PKA) following agonist stimulation is required for B2AR sorting to specific tubular domains
from which it can signal via Gs. PKA inhibition or mutating SS345/6 to alanine residues that cannot be
phosphorylated prevents B2AR signaling from endosomes. These manipulations also increase the rate at which
B2AR recycles to the plasma membrane by allowing the receptor to enter additional bulk recycling tubules which
are unavailable to wild type B2AR and from which it cannot signal. The protein interactions governing this
regulation are unknown. Phosphorylation of SS345/6 is also regulated by the presence of palmitoylation at B2AR
cysteine 341. Abolition of palmitoylation at this site results in a significant increase in basal SS345/6
phosphorylation in the absence of agonist stimulation. This proposal tests the role of specific protein complexes
in localizing B2AR to specific intracellular membrane domain, the role of phosphorylation and palmitoylation in
this localization, and the functional relevance of this localization to signaling in the heart. I will use fluorescence
microscopy and quantitative real-time PCR to determine the impact of candidate proteins on B2AR sorting to
endosomal microdomains and signaling from these compartments in both HEK293 cells and primary
cardiomyocytes. I will also use novel unbiased proximity labeling approaches to identify and quantify transient
interactions of regulatory proteins with wild type, phosphorylation-deficient, and palmitoylation-deficient B2AR.
The role of palmitoylation in regulating this process will be examined using functional genetics and microscopy
with conformational biosensors that can identify both B2AR localization and signaling. The proposed research,
by characterizing pathways with significant impact on the function of cardiomyocytes, will potentially identify new
druggable targets that improve the function of the failing heart and alleviate heart failure.

Public health relevance
PROJECT NARRATIVE G protein coupled receptors are the target of many drugs used in the treatment of cardiovascular diseases, but the way in which signaling from different compartments in the cell regulates their function and response to drugs is only partially understood. The proposed research will investigate how the action of the beta 2 adrenergic receptor, a prototypical GPCR and important signaling protein in heart failure, is regulated by sorting to microdomains of the endosome after internalization. Greater understanding of the mechanisms regulating B2AR sorting from internal compartments will aid us in identifying new options for modulating the action of this important drug target.